Project 1 – Development of Orally Bioavailable beta-CoV Inhibitors

Project Summary – Project 1
The COVID-19 pandemic is exerting an unprecedented health and socioeconomic impact. Despite the rapid
generation of vaccines, vaccination hesitancy, emergence of viral variants of concern (VOC), and breakthrough
cases have fueled continued community transmission, creating utmost urgency for the development of next-
generation antiviral drugs. Typically narrow therapeutic windows define a clear directive to treat early and rapidly
build high tissue exposure to maximize the benefit of pharmacological intervention in acute RNA virus infections.
Groundbreaking expansion of diagnostic capacity combined with efficient contact tracing have established
infrastructure to identify SARS-CoV-2 transmission before the onset of specific clinical signs. Oral bioavailability
and high tolerability are in our view key drug properties to efficiently serve the needs of an outpatient group.
Direct-acting antivirals appear to be best suited to combine high potency with an appropriate safety profile.
We have previously identified the orally efficacious nucleoside analog inhibitor EIDD-2801/molnupiravir and
established proof-of-concept for pharmacological suppression of SARS-CoV-2 spread to untreated contacts
using the ferret transmission model. It is the overarching goal of this AC/DC project to harness our demonstrated
expertise in the development of applicable therapeutics and de-risk a mechanistically and structurally distinct
companion drug to molnupiravir and at least one independent alternative to the stage of formal development. In
pilot studies, we have identified a novel uridine analog that shows outstanding oral pharmacokinetic (PK)
properties in different species, broad-spectrum antiviral activity in cultured cells and primary human airway
epithelium organoids, acts through induction of delayed polymerase chain termination, and is orally efficacious
against SARS-CoV-2, VOC, and several other viral pathogens of pandemic potential. To broaden our anti-CoV
portfolio, we will in a multi-pronged approach simultaneously advance an early-stage adenosine analog anti-CoV
hit and, having pioneered recombinant SARS-CoV-2 reporter virus technology and miniaturized a high-
throughput screening (HTS) protocol, launch an anti-SARS-CoV-2 campaign using our established high-
biocontainment HTS facilities. To prepare for formal development, the nucleoside analog classes will be
subjected to full mechanism of action characterization, resistance profiling, and assessment of off-target effects
(aim1). Non-nucleoside anti-CoV hit candidates from HTS will be validated through direct and orthogonal
counterscreens, viral target identification, and indication spectrum and mechanistic profiling (aim 2). Confirmed
nucleoside analog and non-nucleoside CoV inhibitors will be synthetically optimized in iterative rounds, driven
by antiviral potency, PK properties, tolerability, and insight into the molecular docking pose (aim 3). Emerging
leads will be de-risked using the ferret and dwarf hamster models of SARS-CoV-2 infection, pathogenesis of
compound-experienced VOC assessed, dosing paradigms explored through interfacing of dynamic PK profiles
with performance in human organoids, and results validated in a non-human primate COVID-19 model (aim 4).